Regulation of Innate Immunity and Inflammation Through Nuclear Reprogramming

PROJECT SUMMARY
Regulation of Innate Immunity and Inflammation Through Nuclear Reprogramming
We propose to advance our mechanistic studies of innate immunity and inflammation in severe infections that
evolve into their end stage, septic shock, thereby threatening the lives of wounded soldiers on the battlefield, our
Veterans, and the civilian population. Those Veterans (and non-Veteran patients) between the ages of 65 to 85
are particularly prone to septic shock with a 45% mortality rate while many survivors suffer debilitating cognitive
decline. We are pursuing our long-term goal to decode innate immunity and inflammation with a new class of
cell-penetrating Nuclear Transport Modifiers (NTMs) that reprogram the inflammatory regulome. One of these
anti-inflammatory peptides achieved an unprecedented enhancement of innate immunity-mediated bacterial
clearance in the lungs (700-fold), spleen (300-fold), and blood (200-fold), all taking place before antimicrobial
therapy. Concurrently, it improved the blood markers of microvascular endothelial injury, including
thrombocytopenia. When combined with anti-microbial therapy, NTM increased the survival rate to 55%,
compared to a 30% survival rate in the antibiotic-only group. This NTM peptide, cSN50.1, simultaneously targets
two nuclear transport shuttles, importins α5 and β1. To unravel the mechanism of innate immunity and
inflammation that underlie microbial and metabolic disorders, we designed, produced, and tested two novel
mono-selective NTMs: (i) Importin α5-selective cSN50.1α, and (ii) Importin β1-selective cSN50.1β. Strikingly,
the importin α5-selective peptide produced an 80% survival rate in endotoxin shock induced by
lipopolysaccharide (LPS), one of the most potent virulence factors of Gram-negative bacteria responsible for two
thirds of septic shock cases. This new NTM also effectively controlled the Western Diet-induced hypersensitivity
to lethal endotoxin shock while preventing liver glycogenolysis, which causes hyperglycemia and
hypertriglyceridemia linked to the nuclear transport of Carbohydrate Responsive Elements-Binding Proteins
(CHREBPs). In turn, the Imp β1-selective peptide suppressed lipogenesis mediated by the nuclear transport of
the Sterol Regulatory Element-Binding Proteins (SREBPs) that control over 30 genes involved in the production
of triglycerides, cholesterol, and fatty acids, a hallmark of metabolic syndrome. We hypothesize that the proposed
use of selective NTMs with antimicrobial agent(s) would untangle multiorgan damage and mortality in severe
infections. Furthermore, we posit that the Importin α5/SRTFs/CHREBPs and Imp β1/SREBPs pathways are
interdependent, thereby predisposing individuals with metabolic syndrome to hyperacute responses to severe
infections. Hence, in Aim 1, we will investigate the mechanism of the NTM’s beneficial action in polymicrobial
peritonitis (i.e. the striking enhancement of the innate immunity-mediated clearance of bacteria in the lungs,
spleen, kidneys, and blood prior to antimicrobial therapy) by suppressing either Imp α5/SRTFs/ChREBPs or
Imp β1/SREBPs transport. In Aim 2, we will analyze the mechanism of the survival gain through the timed and
selective inhibition of Imp α5/SRTFs/ChREBPs or Imp β1/SREBPs transport without and with antimicrobial
therapy. The new selective NTMs will significantly deepen our mechanistic understanding of innate immunity
reprogramming using genomic and immunometabolic approaches. Thus, the new pathway-selective NTMs offer
us a unique opportunity to (i) decode the transcriptional mechanism of septic shock that integrates microbial and
metabolic inflammation and (ii) to develop clinically relevant strategies to reduce the incidence of septic shock,
increase survival, and reduce long-term cognitive decline in survivors.

Public health relevance
Regulation of Innate Immunity and Inflammation Through Nuclear Reprogramming This project is focused on the mechanistic analysis of the unprecedented enhancement of innate immunity- mediated clearance of bacteria in the lungs, spleen, and blood by a new class of cell-penetrating peptides. These anti-inflammatory peptides selectively target proinflammatory and metabolic nuclear transport pathways. We will also decode both the mechanism of the inflammatory and metabolic injury to multiple organs and increased survival in septic shock. We anticipate that this project will unravel the new genomic and immunometabolic mechanisms of this novel intracellular immunotherapy intended to be combined with antimicrobials. Thus, our innovative anti-inflammatory peptides, coupled with antimicrobials, will pave the way for the improved treatment of severe infections evolving into septic shock in wounded soldiers, Veterans, and the civilian population, thereby reducing the incidence, mortality, and post-septic shock sequelae (such as cognitive decline) in survivors.